Society of Behavioral Medicine 2023 Annual Meeting & Scientific Sessions

PROJECT ABSTRACT
The Society of Behavioral Medicine (SBM) will hold its 44th Annual Meeting & Scientific Sessions April 26-29,
2023, in Phoenix, AZ. This application seeks funding in support of meeting programming addressing the
following specific aims: (1) Train attendees in the skills necessary to improve individual and public health as
well as reduce health disparities by meaningfully including diverse voices in their research and practice (e.g.,
inclusion of racial/ethnic and gender minorities, leading cross-disciplinary collaborations, and involving industry
and community partners); (2) Showcase innovative models for designing and promoting health solutions,
including via influencing behavior at the individual, family, community and policy levels; and (3) Enhance the
diversity of behavioral medicine professionals by providing mentoring, leadership training, professional
development, and networking opportunities to trainees, junior and mid-career faculty, clinicians, industry
professionals, underrepresented individuals, and others who attend the meeting. SBM is the nation’s leading
scientific society dedicated to behavioral medicine, representing approximately 2,400 researchers and
clinicians from more than 20 disciplines. SBM’s members include researchers, clinicians, educators, and
industry professionals who focus on the development and integration of behavioral, psychosocial, and
biomedical theory, knowledge, and interventions relevant to the understanding of health and disease. They
work to understand, prevent, and treat chronic diseases such as cardiovascular diseases, respiratory diseases,
diabetes, and cancer. They conduct research and translate findings into real-world settings to improve lives
while also reducing healthcare costs. SBM’s annual meetings are the premier forum for disseminating
behavioral medicine’s important ideas and breakthroughs. The meeting’s educational sessions, networking
events, interactive research spotlights, and poster/exhibit halls facilitate exchange of information and ideas.
Attendees apply the knowledge gained to disease prevention and management, and development of
innovative research designs, effective interventions and strategies, and evidence-based policies. An estimated
2,000 individuals from the United States and abroad will attend the 2023 SBM Annual Meeting, which will
feature more than 1,500 presentations. The meeting theme is “Translating Science into Impact.” Barriers to
translating science into real-world impacts, include difficulty communicating across disciplines, lack of attention
to stakeholders’ priorities, and lack of awareness about behavioral medicine in some settings. The 2023
Annual Meeting will showcase success stories in translating behavioral science into real impact, and it will
prepare attendees to increase the impact of their own work. Sessions will address translation as it relates to
intervention design, health guidelines, healthcare laws, and systemic changes that advance health equity.
Most of the world’s health challenges have behavioral origins. Behavioral medicine and the evidence it
generates are more important than ever.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The Society of Behavioral Medicine’s 44th Annual Meeting & Scientific Sessions, to be held April 26-29, 2023, in Phoenix, AZ, will bring together 2,000 of the nation’s leading behavioral scientists, clinicians, educators, and policymakers to exchange new research on improving health through behavior change, in particular by translating science into impact. Through a broad range of scientific presentations, discussions, and skill- building workshops, the meeting will facilitate the exchange of the latest population‐level, clinic‐based, and experimental research on the prevention and treatment of the leading causes of morbidity and mortality, with the goals of improving health behaviors, reducing the burden of chronic disease, improving health inequities, lowering healthcare costs, and bettering our nation’s health.